Elucidating the Necessary Components and Mechanisms of Cognitive Training

Loss of independence, difficulties in everyday function, cognitive decline, Mild Cognitive Impairment (MCI), Alzheimer’s Disease (AD) and Alzheimer’s Disease Related Dementias (ADRD) are areas of great concern for older adults and their families. From a public health perspective, successful efforts that enable older adults to age within their homes, as compared to nursing homes, will save an estimated $80 billion dollars per year. Cognitive training is a low cost, noninvasive intervention that has repeatedly demonstrated reliable transfer effects to maintained cognition, everyday function, health, and most recently, a 29% reduction in incident ADRD. Importantly, many of these everyday function effects are maintained across five to ten years including: maintained driving mobility, 50% reduction in at-fault vehicle crashes, and maintained Instrumental Activities of Daily Living (IADL). Despite this promising evidence, the moderators and mechanisms underlying this program are unknown. Our overall objective in this planning grant is to lay the conceptual and methodological foundation to identify cognitive, psychosocial, lifestyle behaviors, biomarker, and neural mechanisms of two forms of conceptually driven cognitive training. Additionally, we will examine how cognitive and psychosocial factors within daily life account for the transfer of cognitive training to everyday function. We will use a factorial design to randomize adults ages 45-90 to 10, 20, 30, or 40 hours of two forms of cognitive training, a combined training, or an active control condition. This study will allow us to test the feasibility of our enrollment, assessment and training protocols for a future multisite clinical trial. This exploratory study is the first of its kind and will be used to provide important data relevant to a future larger randomized controlled trial examining mediators of cognitive training in a representative sample of adults. This information will guide future development and evaluation of affordable and more effective home- and community-based interventions that maintain everyday function and reduce the risk of Mild Cognitive Impairment (MCI), Alzheimer’s Disease (AD) and Alzheimer’s Disease Related Dementias (ADRD).

Public health relevance
Project Narrative Cognitive training is directly relevant to public health as it is a noninvasive behavioral intervention that targets maintained health, everyday function, and maintained independence in older adults. The proposed planning project will collect preliminary data exploring the moderators and mechanisms of cognitive training for a future research project.